Immunologic and Microbial Mechanisms of Inflammatory Bowel Diseases Therapy Failure

Project Summary
Candidate: Simon M Gray, MD, PhD is a fellowship-trained board-eligible Gastroenterologist committed to im-
proving the lives of patients with inflammatory bowel diseases (IBD) by understanding the causes of IBD. As a
Clinical Instructor of Medicine at the University of North Carolina at Chapel Hill, he is focused on developing
strategies to maintain durable IBD remission by understanding triggering events and preventing IBD therapy
failure. The specific training objectives of this K08 are to develop expertise in 1) bioinformatic analysis of micro-
bial metagenomics and host transcriptomics datasets and 2) statistical modeling of complex datasets. This train-
ing will be led by an expert team of 5 mentors/advisors, including R. Balfour Sartor, MD and Timothy Hand, PhD.
Environment: UNC-Chapel provides the ideal environment for the proposed research. The NIDDK P30-funded
Center for Gastrointestinal Biology and Disease is a community of scientists with synergistic interests and skills
in mucosal immunology, gut microbes, and multi-omics that provides a rich reservoir of mentors and advisors
who will guide Dr Gray to accomplish the proposed research. UNC hosts the NIH National Gnotobiotic Rodent
Resource Center, which is a critical resource for Dr Gray’s germ-free mouse studies. UNC has demonstrated its
strong commitment to Dr Gray’s career by providing salary and project support to develop his research program.
Research: Over 50% of IBD patients who achieve remission with immune-targeting drugs suffer therapy failure
within 3 years despite maintaining therapeutic drug levels. I have developed a first-of-kind pre-clinical mouse
model of experimental colitis remission and relapse to study the causes and mechanisms of IBD therapy failure.
This model is clinically relevant because it integrates key features of human IBD (human microbes, FDA IBD
therapy, a trigger-diet to elicit relapse) in colitis-prone Il-10-/- mice that mirror human IBD. IBD is caused by
abnormal CD4+ T-cell mediated immune responses to gut microbes. IBD flares are strongly associated with the
pathogenic gut bacterium C difficile. I use human IBD patient derived stool with or without C difficile to induce
colitis in ex-germ-free Il-10-/- mice. This replicates clinically relevant disease because I found that 23% of my IBD
patients are colonized with C difficile. After developing colitis, Il-10-/- mice achieve disease remission when
treated with anti-IL-12/23 monoclonal antibodies, a 1st line FDA-approved human IBD therapy, even with the
presence of toxigenic C difficile. Critically, feeding these mice in remission a diet associated with human IBD
flares triggers recurrent gut inflammation despite continuing anti-IL12/23 IBD therapy. This therapy failure is
associated with a >10-fold expansion of C difficile in the gut. I hypothesize that diet triggers C. difficile to induce
chronic gut inflammation, despite anti-IL12/23 blockade, by shifting mucosal immune responses to uninhibited
(non-IL12/23) inflammatory pathways driven by expanded CD4+ T cell clones reactive to dominant resident bac-
terial antigens. Aim 1 will define the role of C difficile in therapy failure, aim 2 will identify the non-IL12/23 immune
pathway(s) mediating therapy failure, and aim 3 will identify the CD4+ T cells expanded in IBD therapy failure.

Public health relevance
Project Narrative Over 50% of patients with inflammatory bowel diseases (IBD) who achieve remission with an immune-targeting drug suffer therapy failure despite maintaining therapeutic drug levels. Managing IBD therapy failure is arguably the biggest unmet need in IBD, yet we understand little of this process because therapy failure is difficult to mechanistically study in humans due to high cost, complex logistics, and ethical considerations, and since no animal model of therapy failure exists. I developed a first-of-kind pre-clinical mouse model of experimental colitis remission and relapse/therapy failure, which I will apply in this proposal to study the microbial and immunological mechanisms of IBD therapy failure.